Testing the effects of a text message caregiver support intervention for Latinos

ABSTRACT
Family caregiving for individuals with Alzheimer’s disease and related dementias (ADRD) has a serious
emotional, physical, and financial toll. Latino family caregivers of individuals with ADRD experience a
disproportionately poorer mental health than non-Latino Whites and are less likely to access caregiver support.
Text messaging can dramatically enhance the access of effective culturally and linguistically tailored caregiver
support interventions among Latinos. However, to our knowledge, no text message interventions exist to
provide caregiver support among caregivers of individuals with ADRD. To address this need, we developed
CuidaTEXT (Spanish for self-care and texting; cuídate + text) using a set of user-centered principles.
CuidaTEXT is a bilingual (English and Spanish) 6-month text message intervention that includes daily
automatic messages tailored to Latino caregivers. All caregivers receive one core daily automatic message on
five domains: ADRD education, social support, self-care, ADRD care management, and behavioral symptoms.
Caregivers can access on-demand automatic messages to expand on the five domains by sending keywords
and interact with a coach via a live chat for more personalized help. Preliminary findings from our one-arm
feasibility study (n=24) showed CuidaTEXT was highly usable with high levels of satisfaction and engagement,
increased preparedness for caregiving and approach-coping, and decreased caregiver behavioral symptom
distress and depressive symptoms at 6 months. The next logical step is to assess the efficacy of CuidaTEXT.
Therefore, we will conduct a randomized clinical trial (RCT) to test the efficacy of CuidaTEXT among Latinos.
This research corresponds with Stage 2 of the NIH Stage Model for Behavioral Intervention Development
(efficacy testing) and will also assess CuidaTEXT’s mechanisms of change informed by the Science of
Behavior Change, the Stress Process Framework, and our quantitative feasibility data. We will randomize
caregivers (n=144/arm) to 6 months of CuidaTEXT +1-month post-treatment or a 7-month waitlist control
group. In Aim 1, we will determine the effects of CuidaTEXT on Latino caregiver stressors and their negative
consequences (outcomes). Outcomes include change in caregiver depressive symptoms and behavioral
symptom distress from baseline to 6 months. In Aim 2, we will explore CuidaTEXT’s effects on ameliorating
factors of stress (targets). Targets include changes in caregiver approach-coping and preparedness for
caregiving from baseline to 6 months. In Aim 3, we will examine the mediation of ameliorating factors on
CuidaTEXT’s outcomes. We will test whether CuidaTEXT affects outcomes from Month 3 to 6 by engaging
targets from baseline to Month 3.

Public health relevance
PROJECT NARRATIVE Latino families with Alzheimer’s disease and other dementias (ADRD) experience substantial disparities in mental health outcomes and access to caregiver support. This project will address these disparities by testing the efficacy of CuidaTEXT, a text message intervention to support Latino caregivers of people with ADRD.